Corticosteroids for Acute Exacerbations of Idiopathic Pulmonary Fibrosis: Patterns and Outcomes

PROJECT SUMMARY
In the proposal entitled, “Corticosteroids in Acute Exacerbations of Idiopathic Pulmonary Fibrosis: Practices
and Outcomes” I will determine current practice patterns and outcomes associated with corticosteroid therapy
for acute exacerbations of idiopathic pulmonary fibrosis in critically ill patients. Every year, 10-20% of patients
with idiopathic pulmonary fibrosis (IPF) – a progressive, fibrosing lung disease – experience acute
exacerbations (AE-IPF), often leading to hospital admission and critical illness. These acute respiratory
deteriorations result in high morbidity and mortality for IPF patients; patients who develop critical illness have
in-hospital mortality rates of 20-35% and a median survival post-exacerbation of 3-4 months. Corticosteroids
are a mainstay of therapy for patients with AE-IPF based on weak evidence, and guidelines do not make
recommendations as to dosing, route, timing, and duration of corticosteroids. Given lack of clear guidelines
and evidence, use patterns are likely highly variable. Expert consensus has called for new evidence to guide
AE-IPF management. In this proposal, I will fill these large knowledge gaps by 1) characterizing practice
patterns of corticosteroid dosing, route, initiation timing, and duration for AE-IPF in a large, national cohort and
2) determining outcomes associated with dosing strategies for corticosteroids using comparative effectiveness
methodology. Completion of this proposal will help inform future studies for AE-IPF management and build an
evidence base for best practices. In addition to the direct experiential learning provided by completion of this
proposal, I will partake in didactics, scientific seminars, and research conferences throughout this award
period, in order to advance my competency in clinical research design and methodology. Further, I will obtain
the skills necessary for data collection and statistical analysis using large databases. With the direct
mentorship of my sponsors, the supportive environment of The Pulmonary Center at Boston University Medical
Center, and professional development courses, I will successfully incorporate the results of this proposal into a
Career Development Award where I will focus on implementing best practices for corticosteroid use in AE-IPF.
This proposal is directly aligned with the goals of the National Heart, Lung, and Blood Institute objectives which
include optimizing clinical research to improve health and reduce disease and leveraging new opportunities in
data science to open new frontiers in heart, lung, blood, and sleep research. This research grant will be
performed under the direct mentorship of two health services investigators with expertise in critical care
epidemiology and outcomes research and under the advice of a comparative effectiveness methodological
expert and two experts in idiopathic pulmonary fibrosis.

Public health relevance
PROJECT NARRATIVE Acute exacerbations are a common complication of idiopathic pulmonary fibrosis (AE-IPF) that can lead to critical illness and are associated with high mortality. Management frequently involves corticosteroids based on case reports of benefit; use patterns and outcomes with corticosteroids for AE-IPF remain understudied. The goal of this proposal is to describe patterns of corticosteroid use for AE-IPF in the United States and to explore the association of dosing strategies with patient outcomes in order to improve management and outcomes for critically ill patients with AE-IPF.